Training in Translational Research in Pulmonary Vascular Biology

Biomedical investigators are experiencing a limitation in their collective ability to translate the remarkable basic science discoveries of the current era into the clinical arena—a divide appropriately termed “the valley of death.” In our first two funding cycles, we have established a strong T32 postdoctoral training program in bench-to-bedside research methodology designed to train the next generation of clinical and basic researchers in translational approaches to pulmonary vascular biology and medicine. The program has thus far trained twenty-three trainees, who have had significant success in publication, grant funding, and securing academic positions. Our program recognized the necessity for practical training in scientific entrepreneurship and biotechnology, and our efforts in bolstering this aspect of training have resulted in three trainees obtaining an MBA. In the third cycle of funding, we will continue to evolve and enhance our training program. In response to our trainees’ requests for entrepreneurship education without the commitment to obtaining an MBA, we have added options for micro-credential programs and formed an Entrepreneurship Educational Board. Further, to enhance the training of our post-doctoral trainees and expand the scope of our program, we will informally include participation by local pre-doctoral trainees in select components of our existing curriculum. Importantly, our post-doctoral trainees will continue to be co-mentored by a faculty with complementary research approaches to provide comprehensive training, and projects focused on patient-oriented bench-to-bedside research, with constant attention to trainee career development. Our faculty include translationally-focused physician-scientists and PhDs spanning basic science to entrepreneurship, with a history of productivity in pulmonary vascular biology, excellent funding support, successful mentoring, and expertise from molecular discovery to clinical trials to biotechnology commercialization. Substantial institutional support is available through endowments to the VMI. The proposed training program, leadership, advisory boards, training faculty, and infrastructure at the University of Pittsburgh are strongly positioned to build on an already rich bench-to-bedside translational training program and create a generation of researchers committed to spanning the “valley of death” between basic research discoveries, clinical application, and commercial viability in pulmonary vascular disease.

Public health relevance
PROJECT NARRATIVE While there have been major biomedical science discoveries over the last two decades, we still face a steady decline in our collective ability to translate these remarkable basic science discoveries into new drugs and treatments for patients. In this training program, we address this challenge directly with a creative approach to training early career physicians and basic scientists in the essential tools for translational patient-oriented research, drug development, and commercialization of basic discoveries. We implement this training in the scientific context of the study of high blood pressure in the lungs, an important and common complication of many heart and lung diseases.